Multi-modality optical imaging of single-cell dynamics using supercontinuum light source

Project Summary
The objective of this study is to develop a multi-modality imaging platform that integrates
complex phase microscopy (CPM) based on optical computation and fluorescence microscopy
(FM). We will use the imaging platform to correlate the sub-cellular dynamic motion and
intracellular properties to study cell adhesion which plays an important role in many aspects of
cell behavior. This study is significant for fundamental research, preclinical and clinical study,
and technology development. By simultaneously imaging cell motion and organelle properties,
CPM-FM enables the investigation of cell dynamics in correlation biomolecular characteristics.
CPM-FM investigation of cell adhesion will result in better understanding of pathophysiology of
different diseases, open the door to new methods for disease treatment and early diagnosis,
lead to the development biomaterials that need specific interaction with cells, and benefit
patients and clinicians. This study will also establish the feasibility of CPM as an imaging
technology that allows non-invasive, and continuous monitoring of cell activities without contrast
agents. Particularly, a supercontinuum light source with broad bandwidth, high spatial
coherence and large output power will be acquired and used as the light source for the imaging
system, to achieve nanoscale displacement sensitivity, sub-micrometer level spatial resolution
and rich molecular information from multiple fluorescence probes. The acquisition of the
powerful light source is expected to enhance our research capability significantly.

Public health relevance
Project Narrative The objective of this study is to develop a multi-modality imaging platform that integrates complex phase microscopy (CPM) and fluorescence microscopy (FM) to investigate how sub- cellular dynamics and intracellular properties are correlated in many importance processes such as cell adhesion. A supercontinuum light source with broad bandwidth, high spatial coherence and large output power will be acquired and used as the light source for the imaging system, to achieve nanoscale displacement sensitivity, sub-micrometer level spatial resolution and rich molecular information from multiple fluorescence probes.